Augmenting Ankle Plantarflexor Function and Walking Capacity in Children with Cerebral Palsy

PROJECT SUMMARY
A child’s ability to walk effectively is essential to their physical health and general well-being. Unfortunately, many
children with cerebral palsy (CP), the most common cause of pediatric physical disability, have difficulty walking
and completing higher-intensity ambulatory tasks. This leads to children with CP engaging in levels of habitual
physical activity that are well below guidelines and those of children without disabilities, which in turn contributes
to many secondary conditions, including metabolic dysfunction and cardiovascular disease. There is broad
clinical consensus that plantarflexor dysfunction is a primary contributor to slow, inefficient, and crouched walking
patterns in CP; individuals with CP need more effective treatments and mobility aids for plantarflexor dysfunction.
To meet this need, this proposal aims to evaluate a holistic strategy to address impaired mobility from
plantarflexor dysfunction in CP using a lightweight, dual-mode (assistive or resistive) wearable robotic device.
This strategy combines two complementary techniques: (1) targeted ankle resistance for neuromuscular gait
training that provides precision therapy to elicit long-term improvements in ankle muscle function, and (2)
adaptive ankle assistance to make walking easier during sustained, high-intensity, or challenging tasks. The first
specific aim is to quantify improvement in ankle muscle function and functional mobility following targeted ankle
resistance gait training in ambulatory children with CP. The primary hypothesis for the first aim is that targeted
ankle resistance training will produce larger improvements in lower-extremity motor control, gait mechanics, and
clinical measures of mobility assessed four- and twelve-weeks post intervention compared to standard physical
therapy and standard gait training. The second specific aim is to determine the efficacy of adaptive ankle
assistance to improve capacity and performance during sustained, high-intensity, and challenging tasks in
ambulatory children with CP. The primary hypothesis for the second aim is that adaptive ankle assistance will
result in significantly greater capacity and performance during the six-minute-walk-test and graded treadmill and
stair stepping protocols compared to walking with ankle foot orthoses and walking with just shoes. Both Specific
Aims will explore the participant characteristics (e.g., age, gender, GMFCS level, walking speed, spasticity rating)
that are associated with the greatest improvement in outcomes following each intervention to provide guidance
for future clinical and at-home implementation. The proposed studies will establish fundamental knowledge on
the ability for adaptive ankle interventions to treat walking impairment relative to standard of care in CP.

Public health relevance
PROJECT NARRATIVE Many children with cerebral palsy have difficulty walking, which contributes to drastically reduced levels of physical activity and lower quality of life. This proposal seeks to address ambulatory impairment in cerebral palsy by investigating the use of wearable ankle assistance for mobility augmentation and targeted ankle resistance for gait training. The long-term goal of this work is to establish a holistic, evidence-based ankle therapy for cerebral palsy that increases physical activity and community participation.